SAFETY AND FEASIBILITY OF SINGLE DONOR BLOOD PROGRAM

To establish the feasibility of single-donor programs by documenting that RBCs from a single unit of blood can support the transfusion needs of a neonate.